Development of a novel, non-hormonal female contraceptive device to submit IDE

PROJECT SUMMARY
Venova Technologies is a women-led medical device startup, developing an innovative non-hormonal female
contraceptive device designed to be long acting and side effect free. Venova Technologies is applying for a
Small Business Innovation Research (SBIR) Phase II grant to advance the development of our patent-pending
technology in anticipation of future primate testing and clinical trials. Over the past several decades,
contraceptive innovation has primarily targeted new delivery modes of hormones that follow the same
mechanism of action as the birth control pill, which was FDA approved over sixty years ago. Despite the
availability of numerous types of contraception, many women remain dissatisfied and will discontinue birth
control use; in many cases, the side effects are unacceptable, and available methods do not meet their needs.
The majority of effective contraceptive methods contain hormones and are associated with menstrual changes,
such as irregular or prolonged bleeding or amenorrhea. The only highly effective, reversible, non-hormonal
method in the US is the copper intrauterine device (IUD) which can be associated with increased menstrual
bleeding and painful menstruation. Although other non-hormonal options (such as condoms, cervical caps,
diaphragms, and spermicides) do not alter menstruation, they have high failure rates. Although many women
prefer hormone-free methods, the choice to avoid side effects comes with a higher risk of pregnancy. Venova
Technologies is developing a first-in-class, long-acting, reversible solution to address the critical unmet need
for birth control options without hormonal and copper side effects. Our device does not interfere with the
hypothalamic-pituitary-gonadal axis nor interrupt natural menstrual cycles, and it acts prior to fertilization. We
have demonstrated in simulation models, an ongoing ex vivo study using excised human uterine tissues, a pilot
preclinical study in primates, and an ongoing sperm efficacy study that our device: (1) functions under
simulated physiological conditions; (2) can be easily placed and retained ex vivo in human tissues; (3) can be
tolerably worn in vivo during menses and will not alter the vaginal microbiome, induce an inflammatory
response, nor cause uterine and cervical tissue necrosis; and (4) provides contraceptive protection by
completely blocking sperm in vitro. In this Phase II project, Venova Technologies will proceed with optimizing
the device and manufacturing process towards clinical production and conduct the FDA-required
biocompatibility testing. The expected outcomes of this Phase II program are a finalized clinical device and a
complete biocompatibility data package, which will enable Venova Technologies to proceed with FDA approval
to conduct a first-in-human Pilot Study. Our mission fully aligns with the NICHD Strategic Plan 2020 and the
Contraception Research Branch priorities to address the unmet needs in women’s health with improved
methods of female contraception. Providing more user-focused and acceptable methods of contraception will
have immense positive health and socioeconomic benefits for women and their families.

Public health relevance
PROJECT NARRATIVE Forty percent of pregnancies in the United States are unintended each year, leading to the increased risk of adverse outcomes for mothers and their babies, including low infant birth weight, premature birth, inadequate or delayed prenatal care, and maternal morbidity and mortality. Many women inconsistently use or discontinue use of their contraceptive method because of unwanted side effects associated with hormones and copper. Venova Technologies is developing a first-in-class, non-hormonal, non-metal, long-acting female barrier device to address the unmet user need and untapped market for highly effective side-effect-free contraception.